Calcium and MAPKinase Signaling and Structural Remodeling in Atrial Fibrillation

Atrial fibrillation (AF) is the most common rhythm disturbance in the US and other developed countries. AF
significantly affects the lives of the afflicted, causing symptoms that range from palpitations to fatigue,
weakness, activity intolerance, stroke, congestive heart failure and death. The impact on public health is
substantial, with more than 450,000 hospital admissions per year and $26 billion in healthcare costs.
Adding to the problems caused by AF is the lack of safe and effective therapies for this rhythm disorder.
Pharmacotherapy for AF has a long history of poor efficacy and potentially lethal side effects. Ablation
strategies have made inroads in paroxysmal AF, but they continue to be long, difficult procedures with less
than optimal success rates and too frequent adverse events. Ablation does not cure AF. We propose
development of gene therapy as a new strategy to eliminate AF. Like many other effective therapies, gene
therapy must focus on disease mechanism as a starting point for development. In the case of AF, electrical
and structural remodeling are critical elements of the disease mechanism that we aim to reverse. We have
previously shown the ability to eliminate the action potential shortening and conduction velocity slowing
elements of electrical remodeling with gene transfer of a dominant negative potassium channel mutation
and connexins. We recently found partial reversal of structural remodeling with inhibition of the
calcium/calmodulin-dependent protein kinase II. In this proposal, we hypothesize that calcium and
mitogen activated protein kinase signaling cause AF-related structural remodeling. We explore this
hypothesis in a clinically relevant porcine model of atrial fibrillation and heart failure by using molecular
methods to correlate signaling pathway activation to structural remodeling and specific drug or genetic
blockers of the relevant signaling pathways to more completely connect pathway activation to structural
remodeling. To address our hypothesis, we propose 3 aims: (1) to define and prevent AF-related
structural remodeling caused by calcineurin overactivity; (2) to evaluate ERK1/2 signaling in AF; (3)
to evaluate the effects of multiple signaling pathway blockade on AF-related structural remodeling.
Successful completion of our aims will not only identify critical mechanisms driving AF-related structural
remodeling, but it will also complete a substantial component of the preclinical testing necessary to translate
these investigational agents into clinical therapies.

Public health relevance
Atrial fibrillation is the most common heart rhythm disturbance in the world, significantly affects the lives of the afflicted by causing symptoms that range from palpitations and fatigue to stroke, congestive heart failure and death. Current treatment options are limited by poor efficacy and substantial toxicity. This proposal focuses on developing novel a gene therapy to prevent or reverse the damage that atrial fibrillation causes to the heart and thereby eliminate the ability of the heart to remain in atrial fibrillation.